Clinical and Translational Science Award

The University of Illinois at Chicago (UIC) Center for Clinical and Translational Science (CCTS) seeks to catalyze
translational research, locally and nationally, as part of a national network to improve individual and population
health. Since our initial funding by the NIH in 2009, the CCTS has been a catalyst for mobilizing institutional
support and resources to enhance clinical translational research and expand multidisciplinary training programs
to increase workforce diversity and promote team science. The overarching goal—and driving focus—of the
CCTS is to improve population health, particularly among minorities and underserved populations. Our high-
quality multidisciplinary clinical and translational research, spanning T1-T4 and paired with strengths in
community engagement and implementation science and appreciation for the social determinants of health, help
to accelerate discoveries into practice and policy. Building on our organizational foundation and record of
success, the UIC CCTS is well-positioned to make substantial contributions by collaborating with other hubs,
supporting national CTSA activities, and making unique contributions to community-engaged research with
vulnerable and underserved populations. As we move forward, we will continue to develop streamlined
processes and resources to facilitate research processes and aid collaboration; to develop and prepare a
translational science workforce that is multidisciplinary and comfortable in team science; to use innovative
informatics solutions to advance translational research; and to have ready-to-deploy systems to respond rapidly
to innovative, collaborative projects. We will achieve our objectives through the following global specific aims:
1) Develop a skillful and diverse translational workforce to conduct multidisciplinary team science and advance
translation of discoveries; 2) Engage a broad range of stakeholders in clinical translational research, including
patients, community leaders, health care providers and clinicians, industry and policy makers; and further support
collaboration among the CTSA hubs; 3) Integrate, support, and accelerate clinical translational research across
the full translational spectrum with multiple disciplines and with diverse populations across the lifespan; 4)
Promote advances in study and development of methods and processes of conducting translational science that
will enable advances in translation; and 5) Support the use and advance of innovative informatics solutions to
advance translational research and to help train the CTSA workforce. These aims will direct our course over the
next five years, as we further evolve the clinical and translational enterprise, contribute to the CTSA network,
and advance the health of the people of Illinois and the nation.

Public health relevance
The University of Illinois at Chicago Center for Clinical and Translational Science (UIC CCTS) proposes to continue to be a robust and highly contributory hub in the national CTSA program that both advances and applies clinical translational research in a timely manner and expands and diversifies the clinical translational workforce. The overarching goal - and driving focus - of UIC CCTS is to improve population health, particularly among minorities and underserved populations across the lifespan. Today's health problems are complex, and addressing them requires the integrated collaborative efforts of scientists and practitioners along the translational spectrum, along with processes to overcome translational barriers. We propose a suite of programs and processes that will help accelerate the translation of scientific discoveries into practice and to overcome the challenges of addressing the complex health problems of today.